First Person Point of View Augmented Reality for Medical Training

The physician-to-population ratio is beginning to plateau, and is expected to decline right as the U.S. elderly (and more medically needy) population is on the rise. Thus, the physician workforce may not be able fulfill the U.S. population's demand. In fact, in 2020, the United States may face shortages of 45,400 primary care physicians and 46,100 medical specialists-a total of 91,500 too few doctors. Other projections estimate that the supply of US physicians may decrease even lower, with a shortfall as high as over 200,000 by 2020. Furthermore, the amount of quality time medical students have to learn procedures has drawn concern from researchers. ArchieMD has been developing a medical simulation augmented reality system to combine multimedia technologies with manikins to enable internal anatomy overlays on medical trainers. ArchieMD developed the technology based on a human manikin task trainer combined with 2D and 3D anatomic visual models presented on a screen. Using augmented reality tracking, ArchieMD's 3D imagery of the body's internal anatomy was superimposed over the view of the user, providing additional 3D didactic information while using a task trainer manikin. One of the key limitations of the approach is that it provides a 3rd person Point-of-View (POV) instead of a 1st person POV. While the 3rd person POV approach has utility for group activities and demonstration, it is of lesser value to the individual practicing the procedure. The use of a 1st person POV would enable seamless integration into medical training. This could be enabled through the use of augmented reality glasses or goggles. Recently, a number of exciting developments have occurred with respect to optical see-through augmented reality glasses and goggles. Under this Phase I SBIR project ArchieMD will team with the Gordon Center for Research in Medical Education at the University of Miami to establish proof of concept through a prototype demonstration and pilot evaluation of a 1st person POV augmented reality trainer for invasive medical procedures. This technology has the potential to provide more efficient and scalable training opportunities for our nation's future doctors.

Public health relevance
Public Health Narrative This proposed project could benefit public health by providing a novel method for efficiently and effectively training medical students key clinical skills, thus improving the knowledge and ability of our nation's future physician workforce.